Targeting heme metabolism to initiate an immune response against breast cancer liver metastasis

Project Summary/Abstract
Breast cancer (BC) remains the second leading cause of cancer-related deaths in women in the United
States and late-stage metastatic BC remains incurable. The recent approval of immune checkpoint
inhibitors targeting PD-1 or PD-L1 in metastatic triple-negative BC (TNBC) demonstrates that
immunotherapies may be an effective approach to decrease BC mortalities. However, over half of
metastatic BC patients develop metastasis to the liver, a site that responds poorly to immunotherapies.
Despite high prevalence and mortality rates, few research programs focus on BC liver metastasis and little
is known about the impact of metastatic BC cells on the liver microenvironment. My K99/R00 proposal will
fill this gap in knowledge by equipping me with the training to become an independent tenure-track faculty
at a research-intensive institution with a program on BC metastasis, especially liver metastasis, research.
My postdoctoral work supported by an NCI-T32 and NCI-F32 explored factors secreted by TNBC to
support lung metastasis via immune suppression. My first-author paper showed that aggressive TNBC
secrete cytokines to enhance the number of pro-tumor macrophages. Currently, I am testing the impact of
TNBC heme metabolism by heme oxygenase-1 (HO-1) on immune suppression via its metabolite bilirubin
(BR). I demonstrated for the first time that TNBC cells secrete BR to alter macrophage polarization and
function. However, HO-1 and BR have never been studied in BC liver metastasis, even though my
preliminary data and work from others showed that HO-1 and BR were elevated in BC patients with liver
metastasis compared to those with metastasis to other sites. The overall goals of this proposal are to: 1)
test the impact of tumor cell-HO-1 on immune cells in the metastatic liver via its regulation of suppressive
cytokines and BR; 2) assess the effects of combined HO-1 and PD-1 inhibition on liver metastatic
outgrowth; and 3) test the impact of BC liver metastasis metabolic reprogramming on HO-1 expression.
During the mentored K99 phase, I will work with experts in animal procedures, liver disease, tumor
immunology and metabolomics at the University of Colorado Anschutz Medical Campus (CU AMC). Under
their guidance, I will test the effects of BC liver metastasis-HO-1 on checkpoint inhibitor resistance via
promotion of T cell-mediated immune suppression (Aim 1). Throughout the K99 and R00 phases, I will
also assess the impact of tumor cell-BR on liver cells including resident macrophages known as Kupffer
cells (Aim 2). In the R00 phase, I will test the impact of BC liver metastasis-specific metabolic
reprogramming via HIF-1α on HO-1 and determine if this further supports local immune suppression (Aim
3). With this research plan and my support system at CU AMC, I will advance the field of BC metastasis
research and lay the foundation for my independent research career that will continue to assess the
effects of organ-specific metabolic rewiring on local and systemic immune suppression in BC metastasis.

Public health relevance
Project Narrative Most breast cancer-related deaths are the result of metastatic disease, and yet, some deadly metastatic sites, such as the liver, remain understudied. The project proposed in this application will improve the understanding of breast cancer liver metastasis by assessing the impact of tumor cell heme metabolism on immune suppression within the liver metastatic microenvironment. The goal of this research is to reveal novel therapeutic approaches to enhance anti-tumor immune responses against breast cancer liver metastasis and improve the survival and quality of life of breast cancer patients.